Computer-aided design and development of isoform selective inhibitors of Casein Kinase 1

Project Summary
Protein kinases are essential to cellular function and development, and constitutively activated kinases
have been widely targeted in the development of cancer therapies. Selectivity is a critical issue in kinase
therapeutic discovery and biomedical research, especially in regard to off-target effects. Since the ATP binding
site are highly conserved across the kinome, most ATP-competitive kinase inhibitors suffer from specificity
issues, and the development of specific kinase inhibitors remains a significant bottleneck in modern drug
discovery and biomedical research.
Casein kinase 1 (CK1) is involved in various cellular signal transduction pathways including Wnt/β-
catenin, Hedgehog, and Hippo signaling pathways, and its mis-regulation results in various human diseases.
There are six CK1 isoforms in humans such as CK1α, CK1γ1, CK1γ2, CK1γ3, CK1δ, and CK1ε, and each
isoform displays individual physiological roles in cellular signal transduction. Currently, CK1 isoform-selective
inhibitors are rarely developed, and most of the known CK1-specific agents have been revealed as multi-target
or pan-kinase inhibitors upon further investigation. Thus, it will be a compelling future direction to develop
isoform selective inhibitors of CK1 for the investigation of specific signaling mechanism of CK1 isoforms in
pathophysiological conditions. The objective of this research is to develop isoform selective inhibitors of CK1
via computational analysis, synthetic chemistry, biochemical assays, and structural biology.
Molecular dynamics (MD) simulations of CK1 isoforms will be performed to identify distinct features in
the ATP-binding pocket of each enzyme for the design of selective inhibitors. In addition, the computational
techniques and analysis methods will be applied to explain the mechanisms responsible for selective inhibition
of each isoform. X-ray co-crystal structures of CK1 and our new specific inhibitors will be solved to assist
further design efforts and validate hypotheses generated by computational analysis and molecular modeling.
Multi-step synthesis and characterization of small molecules will be mainly conducted for the optimization of
the potency and specificity of our starting agents and designed compounds. ADP-Glo biochemical assays and
high-resolution Mass Spectrometry analysis will be used to study the inhibition of kinase activity of CK1
isoforms. A series of cell-based proliferation and functional assays will be performed to assess cellular potency
of selective inhibitors such as MTT or CellTiter-Glo cell viability assay and 4E-BP1- and LRP6-phosphorylation
analyses.

Public health relevance
Project Narrative Off-target effects by therapeutic agents are mainly connected to the toxicity of current drug candidates in clinical studies, while achieving specific inhibition of the desired target of interest is a challenging task due to the high degree of similarity among enzymes inside cells. We propose a research plan that combines computational studies, multi-step synthesis, biochemical assay, and structural biology to systematically investigate a family of enzymes and to identify distinct structural features in enzymes of interest. This research will provide new insights into specific inhibition mechanisms for targets of interest, and it aims to produce highly specific chemical agents that may be further developed to new therapeutic candidates.